All optical in vivo cardiac electrophysiology at cellular resolution

Current models of cardiac electrophysiology and arrhythmia focus on the electrical properties of the cardiomyocyte. Recent investigations, though, have begun to establish remarkable roles for non-myocyte cell types, including ﬁbroblasts and immune cells, in cardiac conduction and electrical remodeling after injury. The concept that conduction in the heart depends upon multiple cell types has the potential to alter many of our current hypotheses about arrhythmia generation and promises entirely new approaches to therapy. Revolutionary advances in microscopy, transgenic mouse models, ﬂuorescent reporters, and optogenetics tools are fueling paradigm shifts in our understanding of complex cellular neuronal physiology in the brain. Yet investigations into cellular connectivity in the heart to date have depended upon in vitro examinations of electrophysiology (patch clamping, co-culture) or low resolution readouts of conduction (ECG, conventional optical mapping). This Trailblazer R21 application proposes to overcome limitations of standard optical mapping approaches by creating a new platform for in vivo all-optical electrophysiology studies in the beating heart at cellular resolution. Aim 1 proposes to combine high resolution cardiac intravital microscopy techniques with multiplexed ﬂuorescent reporters and cell-speciﬁc optogenetics actuators to enable simultaneous optical mapping and stimulation of electrical activity in the mouse heart with cellular resolution. Aim 2 will then apply this platform to study the electrical connectivity of myocytes and non-myocytes during healing after myocardial infarction. If successful, this application will signiﬁcantly advance the ﬁelds of cardiac imaging and electrophysiology and will address key questions with clinical implications about electrical remodeling and models of arrhythmia generation after myocardial infarction.

Public health relevance
This project aims to study cardiac electrical activity in the heart at unprecedented resolution down to the cellular level using high resolution intravital microscopy and optogenetics techniques in a mouse model of heart attack. The work promises to provide new insights into the electrical connections between cell types in the heart and the mechanisms of lethal cardiac arrhythmias occurring after heart attack.